teleABLE: Adapting a Behavioral Activation-Based Intervention to Reduce Post-Stroke Sedentary Behavior Using Telehealth

PROJECT SUMMARY/ABSTRACT
This K23 application proposes a career development plan to help Dr. Emily Kringle establish an independent
research program that focuses on optimizing health among adults with stroke-related disability and other
neurological disabilities. She will train under the mentorship of a transdisciplinary group of senior scientists with
research expertise in behavioral clinical trials, stakeholder-engaged intervention development, qualitative
research methods, and interpersonal theories and methods. She will continue working with her current T32
mentors, Drs. Jun Ma and Megan Lewis, both of whom have extensive experience mentoring trainees. This will
be complemented by content and mentoring expertise from Drs. Bethany Barone Gibbs, Elizabeth Skidmore,
and Dilip Pandey. Collectively, this team will provide an outstanding training environment that will allow Dr.
Kringle to fill critical gaps in her knowledge and skill set relating to the study of lifestyles interventions and
interpersonal social dynamics that influence post-stroke sedentary behavior and quality of life. Her training
goals are to develop skills in (1) design and analyses of conventional and contemporary behavioral clinical
trials, (2) qualitative analyses of stakeholder engagement data, (3) theory, measurement, and analyses of
interpersonal (dyadic) influences on post-stroke health behaviors, and (4) professional skills in interdisciplinary
team science and scientific leadership. Achieving these goals will strengthen her scholarly activities, establish
important collaborations, and acquire critical data that will ensure her successful transition to independence. To
this end, Dr. Kringle’s proposed research plan that builds directly on her prior work developing the Activating
Behavior for Lasting Engagement (ABLE) intervention. ABLE uses behavioral activation to reduce post-stroke
sedentary behavior. Reducing sedentary behavior is particularly important for promoting health in the context
of stroke-related disability. Even if impairments (motor, cognitive, sensory) fully resolve, stroke survivors do not
automatically re-engage in non-sedentary activities as impairments diminish. Further, residual impairments,
social influences (protective care providers), and environmental factors (transportation, accessibility) create
barriers to engagement in personally meaningful non-sedentary daily activities. The purpose of this proposal is
to adapt ABLE to telehealth (teleABLE), targeting the first year post-stroke, and evaluate its acceptability,
fidelity, and potential effects in a pilot randomized clinical trial. We will also explore factors that are potential
moderators or theoretically driven mediators of intervention outcomes. Embedded within this trial is data
collection from stroke survivors’ social support person to explore interpersonal (dyadic) influences on post-
stroke sedentary behavior. Findings from this study, in combination with the career development plan, will
enable Dr. Kringle to launch an independent program of research that aims to 1) develop interventions that
reduce post-stroke sedentary behavior to enhance health and quality of life, and 2) elucidate the role of
interpersonal social dynamics in health behaviors and quality of life among adults with stroke-related disability.

Public health relevance
PROJECT NARRATIVE Elevated levels of sedentary behavior are prominent and persistent among stroke survivors and associated with poor cardiovascular and cardiometabolic health outcomes which elevate the risk for recurrent stroke. Engaging key stakeholders to adapt a promising post-stroke sedentary behavior intervention for remote delivery using telehealth will expand its potential reach. Further, findings from the pilot randomized controlled trial will enable future efficacy trials to advance the development of interventions that can reduce sedentary behavior to improve health outcomes after stroke.